Pyroglutamate Amyloid-beta as an Immunotherapeutic Target for Alzheimer's Disease

DESCRIPTION (provided by applicant): N-terminally-truncated and modified amyloid-beta (Aβ) peptides are abundant in cerebral amyloid deposits in Alzheimer's disease (AD). Pyroglutamate Aβ is generated upon N-terminal truncation of Aβ followed by cyclization by glutaminyl cyclase to convert glutamic acid at residues 3 and 11 to pyroglutamate (AβpE3 and AβpE11). Both forms aggregate quickly, resist degradation, and are neurotoxic. It is unclear if either is present in initial Aβ deposition in plaques and blood vessels (i.e., acting as a seed for further deposition) or if they are modified later. However, Alzheimer's disease progression appears to correlate with the presence of Aβ pE peptide aggregates in brain. We hypothesize that pyroglutamate Aβ acts as a seed for Aβ deposition and accelerates inflammation, neurodegeneration and cognitive decline; therefore, targeted removal of this toxic species by immunotherapy will reduce Aβ deposition, inflammation and neuritic dystrophy, and protect against cognitive impairment without disturbing non-pathogenic Aβ. We propose 4 Specific Aims. Aim 1: We will determine if intrahippocampal or intraperitoneal injections of AβpE-containing mouse brain extracts enhance Aβ deposition, inflammation, neurodegeneration and cognitive decline in APP/PS1dE9 transgenic mice with aging in vivo. Aim 2: We will determine if early removal of pyroGlu Aβ prevents general Aβ plaque deposition and neuritic changes, and protects against cognitive decline by passively immunizing (i.p.) male APP/PS1dE9 tg mice with an anti-AβN3pE mAb (07/1), an anti-AβpE11 mAb, a general Aβ mAb (3A1), or PBS weekly from 4-12 mo of age, starting prior to plaque onset. Outcome measures: behavioral, biochemical, and neuropathological analyses. Aim 3: We will determine if removal of pyroGlu Aβ in late stage AD reduces total Aβ and neurodegeneration and improves cognitive deficits by passively immunizing (i.p.) female APP/PS1dE9 tg mice weekly from 12-16 mo of age, starting well after plaque onset. Antibodies and outcome measures are the same as in Aim 2. Aim 4: We will examine the immune response of microglia to pyroGlu Aβ mAbs in acute in vivo studies and in primary microglial cultures in vitro. Our collaborators at Probiodrug AG (Germany) will kindly provide us with 2 high-affinity, highly selective pyroGlu Aβ mAbs (anti- Aβ pE3 and anti-AβpE11), synthetic AβpE peptides, and brain extracts from their transgenic mouse models that accumulate pyroGlu-3 Aβ peptides. Our collaborators at the CND have generously provided the 3A1 general Aβ mAb hybridoma as a control. Importantly, my lab initiated this collaboration and has many years of experience investigating pyroGlu Aβ deposition, inflammation, and Aβ immunotherapy. The overall goal of our study is to determine whether pyroglutamate Aβ proteins (AβpE3 and AβpE11) are therapeutic targets for Alzheimer's disease and, whether clearance by immunotherapy specific for either pyroGlu Aβ species would be efficacious to prevent and/or treat AD.

Public health relevance
Pyroglutamate Aβ is a modified, truncated form of amyloid-beta (Aβ) that is deposited into plaques and blood vessels in Alzheimer's disease brains. Pyroglutamate Aβ (starting at amino acids 3 and 11) is resistant to degradation and is highly toxic in the brain. We will test whether these modified forms of Aβ propagate amyloid deposition, neurodegeneration, and cognitive impairment and, whether removal of them can prevent or treat Alzheimer's disease in a mouse model.